Personalized Cancer Support for Young Adults

PROJECT SUMMARY
Worry and distress in cancer survivors are common, do not correlate with disease severity, and are heightened
in young adults who are going through multiple life transitions related to school, work, relationships, and family.
Moreover, prior studies found that cancer-related worry and distress can plague young adults many years after
initial diagnosis and treatment, sometimes persisting for over 20 years. Thyroid cancer, melanoma, and testicular
cancer represent the 2nd, 3rd, and 4th most common cancer types diagnosed in young adults, respectively. In
addition to being common cancers in young adults, these three cancers share many other similarities, including
accompanying unmet psychosocial needs. Key to managing worry and distress is ensuring individuals have
knowledge about and confidence in their ability to engage in self-management of cancer-specific worry. The
widespread use of mobile devices across diverse groups in the United States, as well as the promise of mobile
health technology for reducing cancer disparities, supports the use of the mobile optimized Personalized Cancer
Support for Young Adults (PerCS-YA) tool to reduce worry and distress while ensuring broad access by young
adults from diverse socioeconomic and geographic backgrounds. Guided by the ORBIT model for the
development of behavioral trials, we will conduct stakeholder-engaged refinement of the proposed intervention
followed by a phase II efficacy trial utilizing a population-based recruitment source (Surveillance, Epidemiology,
and End Results (SEER) – Georgia) as well as an online cancer support community recruitment source.
Optimization will be followed by a process evaluation, in preparation for the future large randomized controlled
trial (RCT). By tailoring to the young adult cancer population, incorporating mobile technology (i.e., PerCS-YA
will be usable across mobile platforms such as iPhone and Android), and offering ongoing interactive support,
there is potential to mitigate young adult cancer survivors’ worry and distress. Ultimately, this proposed targeted
intervention will reduce the burden of cancer for young adult survivors.

Public health relevance
PROJECT NARRATIVE In preparation for a future large randomized controlled trial (RCT) and with active stakeholder engagement, during this proposed planning grant period there will be refinement and then preliminary evaluation of the impact of a tailored mobile optimized psychosocial support tool (named PerCS-YA: Personalized Cancer Support for Young Adults) on cancer-related worry and distress in young adult survivors of thyroid, melanoma, and testicular cancer. By leveraging advances in digital and mobile health and by tailoring the intervention to the young adult population, PerCS-YA has potential to reduce cancer burden and to improve the psychosocial well-being of young adult cancer survivors.